Single-Particle Analysis of Virus Capsids, Bacteria, and Extracellular Vesicles

Project Summary
We are developing micro- and nanofluidic devices to probe virus capsids, bacteria, and extracellular vesicles
at the single-particle level with improved spatial and temporal resolution. Single-particle (or digital)
measurements provide not only improved sensitivity but also insight into population heterogeneity. Information
content is further enhanced by performing these assays in a high-throughput, multiplexed format, where
individual events are tracked, but population statistics are also obtained. We are targeting rare or infrequent
events, which can significantly impact the overall function or fate of a system, because these events are often
obscured when measurements are made on bulk samples. In the first project, we are studying virus capsid
assembly and disassembly. To monitor reactions with capsids, we are designing in-plane nanofluidic devices
with multiple nanopores in series for resistive-pulse sensing, which is a label-free, nondestructive sizing
technique. Resistive-pulse sensing detects events in real time and has sufficient sensitivity to monitor
assembly at biologically relevant concentrations and over a range of reaction conditions. With these
nanofluidic devices, we are evaluating how assembly effectors and chaotropes impact the assembly process
and produce a variety of particle morphologies, including kinetically trapped intermediates and aberrant
structures. In the second project, we are tracking development and aging of bacteria with microfluidic devices
that have integrated nanochannel arrays to physically trap bacteria. The nanochannels confine growth of
bacteria in one dimension, and when coupled with fluorescence microscopy, image analysis is reduced from
a three-dimensional to one-dimensional problem and greatly simplified. Growth and division rates, subcellular
functions, epigenetic effects, and antibiotic response are easily tracked for extended periods of time and
across multiple generations. In the third project, we are profiling N- and O-glycans derived from serum, urine,
and ascites fluid, and their extracellular vesicles. For thorough characterization of these glycans, we are
combining chemical labeling strategies to neutralize and differentiate sialyl linkage isomers with analysis by
microfluidic capillary electrophoresis and capillary electrophoresis-mass spectrometry. Differences in glycan
sizes, degrees of fucosylation and sialylation, and ratios of sialyl linkage isomers are quantified in these
samples. We are using single-particle techniques to characterize the physical and chemical properties of
extracellular vesicles to correlate these properties with their glycan profiles.

Public health relevance
Project Narrative In this project, we are developing instrumentation and methods to study virus capsids, bacteria, and extracellular vesicles at the single-particle level with higher spatial and temporal resolution. Analysis of single particles provides unprecedented insight into biological processes that is often missed when a population is studied as an ensemble. A more thorough understanding of the physical and chemical properties of these systems is of fundamental interest and will lead to improved therapies.